Unlocking the cidal activity of echinocandins against Aspergillus fumigatus

Invasive aspergillosis (IA), caused mainly by A. fumigatus, is the most prevalent invasive mold infection of
immunocompromised individuals and is associated with mortality rates of 35-90%. Only three classes of anti-
Aspergillus drugs exist. The global rise of resistance to the triazole class and the unacceptably high patient
toxicity of the polyene class limits the use of two of these. The remaining class, the echinocandins, are generally
considered effective therapeutic agents as their target is fungus-specific (cell wall biosynthesis) and they exhibit
low toxicity. However, the echinocandins are not fungicidal for Aspergillus species and a paradoxical effect of
treatment, characterized by decreased drug effectiveness with increasing drug concentrations, has been
described both in vivo and in vitro. Likely due to these issues, high incidence breakthrough infections during
echinocandin therapy have been reported. Therefore, echinocandin use for IA is also limited. The discovery of
mechanisms essential for echinocandin stress adaptation and survival is expected to improve therapeutic
efficacy with these important compounds by identifying fungal targets for future combination therapies. To
delineate novel mechanisms orchestrating echinocandin stress responses, we recently completed the
generation of a protein kinase disruption mutant library in a wild type genetic background. This library was
constructed using CRISPR/Cas9 gene-editing to disrupt each of the 142 putative protein kinases encoded by
the A. fumigatus genome. A total of 118 non-essential, unique gene disruptions were achieved and subsequently
employed for in vitro echinocandin susceptibility assays. Our preliminary assays identified a total of 12 protein
kinase disruption mutants displaying 4- to >32-fold decreased minimum effective concentrations (MEC)
compared to the parental strain. We have discovered that two of these mutations, residing in the previously
uncharacterized SepL and SidB kinases, impart fungicidal anti-Aspergillus activity to multiple echinocandins.
These protein kinases are predicted to be core components of the Septation Initiation Network (SIN), a three-
kinase cascade that is necessary for septation in fungi. Our exciting preliminary data show that blocking septation
via loss of any single SIN kinase causes widespread hyphal damage and loss of viability in response to
echinocandin treatment. In addition, employing the sepL disruption mutant, we have found that echinocandin
therapy improves survival and eliminates residual tissue burden in a mouse model of IA. As septa are important
for the limitation of mechanical injury to hyphae, and the A. fumigatus SIN is completely uncharacterized,
exploration of this network is expected to reveal novel effectors of echinocandin stress survival. Our aims are to
identify core SIN components required for unlocking echinocandin cidal activity (Aim 1), define temporal
requirements for enhancement of echinocandin activity resulting from septation blockade (Aim 2), and to
delineate the SIN pathway-dependent septum construction machinery (Aim 3). Our work will identify the SIN
components with the highest potential for benefit when targeted in combination with echinocandin therapy.

Public health relevance
Invasive aspergillosis is associated with high mortality rates in patients with suppressed or ineffective immune systems. Successful treatment of Aspergillus fumigatus infections is difficult, as only three classes of antifungal exist and clinical use of each is met with major limitations. Our research aims to enhance the anti-Aspergillus activity of the echinocandin class through targeting developmental mechanisms that shift echinocandin activity from static to cidal.